Differential artery-vein analysis in OCT angiography for objective classification of diabetic retinopathy

Abstract: This project aims to establish differential artery-vein analysis in optical coherence tomography
angiography (OCTA), and to validate comprehensive OCTA features for automated classification of diabetic
retinopathy (DR). Early detection, prompt intervention, and reliable assessment of treatment outcomes are
essential to prevent irreversible visual loss from DR. It is known that DR can target arteries and veins differently.
Therefore, differential artery-vein analysis can provide better performance of DR detection and classification.
However, clinical OCTA instruments lack the capability of artery-vein differentiation. During this project, we
propose to use quantitative feature analysis of OCT, which is concurrently captured with OCTA, to guide artery-
vein differentiation in OCTA. The first aim is to establish automated artery-vein differentiation in OCTA. In
coordination with our recently demonstrated blood vessel tracking technique, OCT intensity/geometry features
will be used to guide artery-vein differentiation in OCTA automatically. Differential artery-vein analysis of blood
vessel tortuosity (BVT), blood vessel caliber (BVC), blood vessel density (BVD), vessel perimeter index (VPI),
vessel branching coefficient (VBC), vessel branching angle (VBA), branching width ratio (BWR), fovea avascular
zone area (FAZ-A) and FAZ contour irregularity (FAZ-CI) will be implemented. Key success criterion of the aim
1 study is to demonstrate robust artery-vein differentiation in OCTA, and to establish OCTA features for objective
detection and classification of DR. The second aim is to validate automated OCTA classification of DR. We
propose to employ ensemble machine learning to integrate multiple classifiers to achieve robust OCTA
classification of DR. Key success criterion of the aim 2 study is to identify OCTA features and optimal-feature-
combination to detect early DR, and to establish the correlations between the OCTA features and clinical
biomarkers. The third aim is to verify OCTA prediction and evaluation of DR treatment. Our preliminary OCTA
study of diabetic macular edema (DME) with anti-vascular endothelial growth factor (anti-VEGF) treatment has
shown that BVD can serve as a biomarker predictive of visual improvement. During this project, we plan to test
differential artery-vein analysis for DME treatment evaluation. Key success criterion of the aim 3 study is to
identify artery-vein features to provide robust prediction and evaluation of DME treatment outcomes. As an
alternative approach, we propose a fully convolutional neural network (FCNN) for deep machine leaning based
artery-vein and DR classification. Early layers in the FCNN will produce simple features, which will be convolved
and filtered into deeper layers to produce complex features for artery-vein and DR classification. Further
investigation of the relationship between the new features learned through the machine learning process and
clinical biomarkers will allow us to optimize the design for better DR classification. Success of this project will
pave the way towards using quantitative OCTA features for early DR detection, objective prediction and
assessment of treatment outcomes.

Public health relevance
Project Narrative This project is to establish quantitative optical coherence tomography angiography (OCTA) analysis for objective classification of diabetic retinopathy (DR). By translating subjective findings into objective assessments, this study will standardize clinical OCTA for eye disease detection and treatment assessment. In addition, objective OCTA analysis based automated DR classification can foster telemedicine in rural and underserved areas where the access to experienced ophthalmologists is limited.